Methylglyoxal-induced macrophage metabolic dysregulation in sepsis

Sepsis is an aberrant immune response to infection1 with approximately one million cases/year in the
U.S.A. and an overall fatality rate of ~20-30%, increasing to ~40-50% in the case of septic shock1-3. Sepsis is
characterized by stress hyperglycemia4, mitochondrial dysfunction5, and persistent, strongly oxidizing
conditions. Although sepsis is a complex disease involving many different cells and tissues, a better
understanding of the role of macrophages (Mf) during sepsis may reveal new therapeutic targets. Mf exhibit
dynamic, stimulus-dependent functional plasticity in vitro and in vivo and critical changes to their activities
during sepsis are thought to be initiated by bacterial products (e.g., lipopolysaccharide; LPS) and
proinflammatory cytokines (e.g., interferon-g; IFN-g) that reprogram Mf to a highly proinflammatory, “classically
activated” or “M1” phenotyperev. in 6. These signaling pathways also stabilize the transcription factor Hypoxia-
Inducing Factor-1a (HIF-1a)7,8. HIF-1a is a master regulator of glycolytic genes9, facilitating a profound
“metabolic switch,” the “Warburg effect” rev. in 10-12, in M1 Mf in which glycolysis predominates and mitochondrial
oxidative phosphorylation is essentially absent, even when oxygen is present. We propose that this metabolic
dysregulation underlies inflammation during sepsis, by driving production of proinflammatory cytokines as well
as exposure of tissues to damaging M1 Mf-dependent reactive oxygen species (ROS), proteases, and
bioactive lipids. While cytokines and ROS have been extensively studied, less is known about the role of
methylglyoxal (MG), a highly reactive, dicarbonyl byproduct that can accumulate intracellularly during the
glycolytic reaction mediated by triose phosphate isomerase (TPI)14,15. Significantly, elevated MG in sera of
septic shock patients has been identified as a biomarker that correlates with disease severity21. We have
reported that MG accumulates in M1 Mf upon stimulation with LPS and IFN-g in vitro, and results in the
formation of covalent “MG-adducts” with host proteins both in vitro and in the lungs of endotoxic mice17. Our
central hypothesis is that MG, a relatively short-lived, but highly reactive metabolite generated in response to
LPS+IFN-g activation of Mf, directs inflammatory M1 Mf differentiation in sepsis, and that strategies that inhibit
MG production or activity will prevent such differentiation, and thereby reduce Mf-directed inflammation. Our
scientific premise is that selective targeting of MG accumulation can be capitalized upon to mitigate sepsis-
associated tissue damage and death. We propose that LPS + IFN-g-induced stabilization of HIF-1a initiates
sepsis by promoting M1 Mf differentiation through increased glycolysis, MG accumulation, MG-mediated
glycation of mitochondrial proteins that disrupts mitochondrial function. Specific Aim 1 will characterize
mechanisms by which MG accumulation in Mf disrupts mitochondrial function, Aim 2 will examine the role of
metabolic signaling pathways on MG accumulation, and Aim 3 will test the therapeutic efficacy of MG-
degrading enzymes to mitigate endotoxicity and bacterial sepsis.

Public health relevance
The metabolism of anti-microbial white blood cells called macrophages can become dysregulated during infection, leading to sepsis, a severe disease that can be fatal. Our proposed study seeks to identify the underlying mechanism for the metabolic changes associated with sepsis so that new drugs can be developed that normalize the host response to infection.